NK killing of coronavirus-infected cells

Abstract
Natural killer (NK) cells are innate lymphocytes that kill tumor and virus-infected cells, independently of peptide
antigens. NK cells recognize target cells through activating and inhibitory NK receptors, which interact with
specific ligands on the target cell surface. The balance of activating and inhibitory receptor signaling determines
whether target cells are killed. Our lab recently found that the most conserved and universally expressed NK
activating receptor, NKp46, recognizes cells undergoing endoplasmic reticulum (ER) stress by binding to
externalized calreticulin (ecto-CRT), an ER chaperone that translocates to the cell surface under conditions of
ER stress. Ecto-CRT binds to and activates NKp46, leading to killing of tumor, senescent, and Zika virus (ZIKV)-
infected cells. We also found that ER stress during ZIKV infection downregulates the major histocompatibility
complex (MHC) ligands of NK inhibitory receptors. Coronavirus (CoV) replication is tightly linked to the ER. CoV
mature by budding into the ER-Golgi intermediate compartment (ERGIC), where the nucleocapsid-genomic RNA
complex is enclosed within a membrane containing the membrane-bound structural viral proteins, S, E, and M.
These proteins are expressed on the ER. Massive production of viral proteins along with depletion of the ERGIC
membrane by budding and egress of progeny virions disrupts the ER during CoV infection, as shown using
murine hepatitis virus as a model system. Given our previous work showing recognition of ZIKV-infected and ER
stressed cells via NKp46/ecto-calreticulin, we wondered whether CoV-infected cells may also be recognized by
NK via the same interaction. Most papers studying NK responses to SARS-CoV-2 have focused on antibody-
dependent cellular cytotoxicity (ADCC) and are thus measuring a function of NK cells that depends on an
adaptive immune response. Three papers investigated antibody-independent NK cell interactions with SARS-
CoV-2-infected target cells in vitro, and suggest that NK cell co-culture with infected targets suppresses viral
replication by measuring a reduction in viral protein or RNA. However, none of these publications explored how
NK recognize infected cells. In preliminary experiments I assayed for ER stress and CRT externalization during
infection by the avirulent human CoV OC43. My preliminary data confirm that OC43 infection induces
upregulation of ER stress genes and show that CRT externalization occurs during infection. Based on these
data, I hypothesize that CoV replication causes ER stress, externalization of CRT, and downregulation of NK
inhibitory receptor ligands, causing CoV-infected cells to be recognized by NKp46 and killed by NK. I will
investigate this central hypothesis by measuring expression of activating ecto-CRT and inhibitory MHC ligands
on the surface of CoV-infected cells (Aim 1). I will then test the ability of primary and NK cell lines to kill CoV-
infected cells and determine whether the killing of infected cells, if present, is mediated by the NKp46/ecto-CRT
interaction (Aim 2). I will investigate this system using both avirulent OC43 and virulent SARS-CoV-2. The
proposal will further our understanding of how the innate immune system may defend against CoV infection.

Public health relevance
Project Narrative Natural killer (NK) cells are part of the immune system’s first line of defense, recognizing virus-infected or tumor cells and killing them to protect the host. Infection by coronaviruses (including SARS-CoV-2) may render the infected cell a target for killing by NKs, but the mechanism is largely unexplored given the focus on adaptive immunity to coronaviruses. Here, we will investigate a stress-induced signal for innate NK activation that we hypothesize is induced by coronavirus infection and may allow for recognition and killing of the infected cell.